CANCER IN ORIENTAL POPULATIONS

Studies of Oriental populations represent the Division's continuing interest in the health risk among these minority groups for the mapping out of cancer prevention and control programs: 1. An analysis correlating mortality from cardiovascular diseases in 65 mostly rural counties in mainland China with various diet and lifestyle measurements has been completed and accepted for publication. 2. Assembling mortality/incidence figures on Asian populations from various sources, we have established an international file of cancer/non- cancer causes since 1960. These Asian resource data, age-adjusted and age- specific rates, also include figures for U.S. and "homeland" populations.